Implementation of an Evidence Based Parentally Administered Intervention for Preterm Infants.

ABSTRACT
Early developmentally-based behavioral intervention has well-established positive effects and is recommended
as the standard of care to support early brain maturation, health, and development. However, few neonatal
intensive care units (NICUs) provide this early intervention. H-HOPE (Hospital to Home: Optimizing the
Preterm Infant’s Environment) has established efficacy, and has a standardized protocol, making it ready for
widespread implementation. The infant-directed component of H-HOPE provides Auditory (voice), Tactile
(moderate touch massage), Visual (eye to eye), and Vestibular (rocking) stimulation starting when infants are
ready for social interaction. The parent-directed component of H-HOPE includes participatory guidance and
support to help parents engage with their infants in the NICU and the transition to home. In our NIH-funded
research, H-HOPE improved growth, developmental maturity and mother-infant interaction, and reduced initial
hospitalization costs and acute care visits through 6-weeks corrected age. This research tests whether H-
HOPE can be implemented and sustained in five diverse NICUs, using a Type 3 Hybrid design to evaluate
both implementation processes and effectiveness. The specific aims are to: 1) Identify the degree of
implementation success; 2) Evaluate the effectiveness of H-HOPE for infants, hospital costs from H-HOPE
enrollment until discharge, and parents, compared to a pre-implementation comparison cohort; and 3)
Determine influences (facilitators and barriers) associated with implementation success and H-HOPE
effectiveness, guided by the Consolidated Framework for Implementation Research (CFIR). An incomplete
stepped-wedge design guides staggered roll-out for five clinical sites. Each NICU completes the CFIR
implementation steps (Planning and Engaging, Executing, and Reflecting and Evaluating), followed by 6
months of Sustaining. For Aim 1, degree of implementation success is determined every two months as
Sustainability (still offering H-HOPE), Reach (% of eligible parent/infant dyads receiving H-HOPE) and Degree
of Implementation (mean H-HOPE services received per parent-infant unit) (primary implementation
outcomes). For Aim 2, effectiveness is analyzed using generalized linear mixed models for infant, cost, and
parent outcomes (primary outcomes: infant growth at discharge and acute care visits from discharge to 6-
weeks corrected age). Propensity score analysis is used to make the pre- and post-implementation
comparable. For Aim 3, we use mixed methods analyses to identify influences from H-HOPE records and
interviews that are associated with implementation success and effectiveness at each site and across sites.
This is the first time implementation in a NICU is guided by the evidence-based CFIR framework, and results
will make a major contribution to implementation science. This study will produce an evidence-based
implementation strategy and Toolkit to disseminate nationwide. Widespread H-HOPE implementation will make
a significant change in clinical practice and improve preterm infant health and health care costs.

Public health relevance
PROJECT NARRATIVE This study will determine how to successfully implement H-HOPE, a known efficacious developmental behavioral intervention, in neonatal units. These data are vital to deliver early interventions that can promote preterm infant growth and development, improve public health and reduce cost.